ESOPHAGEAL IMPEDENCE MEASUREMENT AND DETECTION OF GASTROESOPHAGEAL REFLUX

Our hypothesis is that there is no difference in detection of reflux episodes by either standard pH ambulatory monitoring and esophageal impedance recordings. Alternate hypothesis: pH monitoring alone is not sufficient to diagnose all reflux episodes especially those that are non-acidic.